2025 Cell Contact and Adhesion Gordon Research Conference and Seminar

Project Summary
Cell-cell and cell-matrix adhesion underlie fundamental biological processes during development and disease.
Advancing this field requires collaboration and communication between scientists in diverse fields including cell
and developmental biology, biochemistry, biophysics, and engineering. The Gordon Research Conference
(GRC) on Cell Contact and Adhesion is the premier gathering for investigators working on basic biology and
therapeutic applications of cell-cell and cell-matrix adhesion. This application requests funds primarily to sup-
port the registration of graduate students, postdocs, and Early-Stage Investigators at the 2025 meeting and the
associated Gordon Research Seminar (GRS) for graduate students and postdocs. The meeting is anchored by
an international community of scientists who are leaders in studying cell adhesion and in training/mentoring the
next generation of scientists. It brings together an interdisciplinary group including cell and developmental biol-
ogists, biochemists, biophysicists, engineers, and scientists working in industry, and provides an exciting forum
for exchanging ideas, tools, and techniques. It provides an outstanding opportunity for graduate students, post-
docs, and Early-Stage Investigators to present their data, gain visibility, receive constructive feedback from
leaders in the field, and engage in impactful community-building. Our aims are:
Aim 1: Provide an interdisciplinary forum to discuss new discoveries in cell-cell and cell-matrix adhe-
sion and help attendees think broadly about how basic science discoveries inform clinical approaches.
Our program will include presentations ranging from those exploring the mechanisms mediating signaling at
cell-cell and cell-matrix adhesions, to those defining the roles of adhesive junctions in morphogenesis, homeo-
stasis, and disease, to those profiling emerging ideas and techniques that will drive future advances. The com-
bination of themes will make this meeting the premier conference in this field next year and will foster genera-
tion of new ideas that drive research forward. The program includes 28 invited speakers representing diverse
fields and career stages, including speakers who are underrepresented minorities or are from outside the US.
16 talks by graduate students, postdocs, and Early-Stage Investigators will be selected from the abstracts.
Aim 2: Build a community among diverse meeting participants from all career stages that exchanges
scientific ideas and mentoring advice. The intimate size and informal setting is central to success of the
meeting and fosters interactions. Graduate students and postdocs showcase their research through a pre-
meeting GRS and in selected talks and posters at the GRC. We encourage an inclusive environment where
diversity of ideas and backgrounds is represented and will employ innovative mechanisms to foster community
building and mentoring of early career scientists. Our Power Hour is on the theme of ‘Time management in Ac-
ademic Research’. Structured and unstructured activities will promote interactions between faculty and train-
ees, including afternoon mentoring discussions, shared meals, and poster sessions.

Public health relevance
Project Narrative The 2025 Gordon Research Conference on Cell Contact & Adhesion and its associated Gordon Research Seminar will bring together a diverse group of scientists to share new findings about how cell adhesion is regulated in development and tissue homeostasis, as well as how these mechanisms are disrupted in diseases. Discoveries about the key molecular players involved in cell adhesion and tissue morphogenesis will aid in understanding the underlying causes of developmental defects such as craniofacial abnormalities and neural tube defects, and the alterations in adhesion that are involved in cancer metastasis. They may also provide a foundation for developing new therapeutic strategies for treating diseases including cancer, vascular diseases (atherosclerosis, fibrosis, abnormal angiogenesis), barrier function diseases (inflammatory bowel disease, Crohn’s disease), and pulmonary epithelial diseases (asthma, chronic obstructive pulmonary disease).